Function of basal synapses at mammalian photoreceptors

Summary
The long-term objective of this project is to understand how the unique structure of the mammalian cone
photoreceptor synapse determines its function in vision. The outer segments of cones, which are specialized
for daylight vision, convert absorbed photons into a voltage signal. In an essential step for visual perception,
the voltage signal spreads to the photoreceptor synaptic terminal where it gates Ca2+ channels that control
the release of the transmitter glutamate onto postsynaptic bipolar and horizontal cells. The cone synapse is
a site at which parallel processing begins in the visual system. A single cone contacts ~14 bipolar cell types,
which in turn carry signals to over 40 different types of retinal output neurons, the ganglion cells, in the inner
retina. The mammalian cone terminal has a complex and stereotyped spatial organization that incorporates
two unique structures, the invaginating and basal junctions. Transmitter is released from sites atop ~twenty
200-400 nm long membrane invaginations that open onto a ~3 µm diameter basal surface. “On” bipolar cells,
cells that respond at light onset, and horizontal cells contact cones within invaginations, whereas “Off” bipolar
cells, which respond at light offset, contact at the base, although there are minor exceptions to these rules.
The different processing functions of basal and invaginating contacts are poorly understood. By recording
from cones and postsynaptic bipolar cells in slices from the cone-dominant ground squirrel retina, the Aims
seek to understand how the cone visual signal is decomposed by the ~14 different types of bipolar cells at
basal and invaginating cone contacts. The first aim seeks to identify novel types of Off bipolar cells and to
characterize their visual functions. An understanding of parallel processing at the cone synapse relies on a
complete identification of the bipolar cell types and a characterization of their signaling properties. The second
Aim addresses the function of Off bipolar cell kainate receptor desensitization during visual stimuli. Receptor
desensitization during strong stimuli may mediate an adaptation that aids visual processing by matching the
full dynamic range of the cone synapse to the level of light intensity variation in the visual stream. A third Aim
addresses the visual function of basal synapses made by On bipolar cells; a type of connection that goes
against the general pattern described above. Experiments will determine whether basally contacting On
bipolar cells mediate a high threshold signaling pathway like that mediated by basally contacting Off bipolar
cells. Finally, a 4th aim proposes to use a new super-resolution microscopy technique, MINFLUX, to visualize
the proteins that link the cone to bipolar cells across the synaptic cleft at invaginating contacts. The completion
of this work will help us understand the mechanisms underlying the first step in parallel synaptic processing
in the visual system. In addition, these structural and functional studies may provide a scientific basis for cone
transplantation and successful reintegration.

Public health relevance
Narrative The goal of this proposal is to provide fundamental knowledge about how the structure of the mammalian cone photoreceptor synapse determines its function in vision. Although this study deals only with healthy cones, it has implications for understanding how vision can be degraded by diseases of the outer retina such as retinitis pigmentosa and macular degeneration and how cone synapses can be restored following photoreceptor transplantationn.